University of Minnesota BIRCWH K12 Administrative Supplement

ABSTRACT
The University of Minnesota’s (UMN) Building Interdisciplinary Research Careers in Women’s Health
(BIRCWH) K12 training program has been continuously funded for over 15 years. The UMN BIRCWH is a
competency-based and interdisciplinary team-mentored research career development program for junior
faculty, or “Scholars” built on the Office of Research on Women’s Health (ORWH) strategic goals. Over the 15
years of funding, our 16 Scholars have successfully published a total of 1,017 (367 first author) manuscripts,
received 22 NIH grants as principal investigator (total funding $48,239,932), 13 Scholars (81%) have been
promoted to associate professor or higher, and 10 Scholars are in leadership positions at the UMN. In addition,
38% of our Scholars (n=6) have been from underrepresented in medicine and research backgrounds. Our
overall UMN BIRCWH training program objectives align with the ORWH and NIH’s priorities for women’s health
and sex/gender differences research, they include: (1) Increase scholarly publications and funding on women’s
health and sex/gender differences research; (2) Increase the number of interdisciplinary research leaders from
underrepresented in medicine and research backgrounds who advance scientific knowledge in women’s health
across the lifespan and in sex/gender differences in health and disease; (3) Foster new cross-disciplinary
collaborations within the University and broader community to increase the impact of women’s health research;
(4) Transform the academic environment by increasing the visibility of interdisciplinary women’s health and
sex/gender differences research; and (5) Effect the timely translation of women’s health research findings to
clinical practice, public health, and policy. The proposed administrative supplement will build on our
successful UMN BIRCWH K12 training program by allowing us to add a new Scholar from an
underrepresented in medicine and research background and four new competency-based curriculum
components including: (1) health equity and antiracism; (2) community-engaged scholarship; (3) academic
leadership; and (4) dissemination and implementation science skills to further train our BIRCWH Scholars in
equity-focused research methods and professional development. This additional underrepresented in medicine
and research BIRCWH Scholar and the new competencies, in addition to the strong multiple-PI team, rigorous
evaluation plan, and highly interdisciplinary mentors will allow for the UMN BIRCWH program to continue to set
the standard for training Scholars from diverse backgrounds in women’s health and sex/gender differences that
meet the ORWH strategic goals.

Public health relevance
PROJECT NARRATIVE This administrative supplement for the University of Minnesota’s (UMN) Building Interdisciplinary Research Careers in Women’s Health (BIRCWH) K12 career development training program will allow our UMN BIRCWH program to add a new Scholar from an underrepresented background and four new competency-based curriculum components including: (1) health equity and antiracism; (2) community-engaged scholarship; (3) academic leadership; and (4) dissemination and implementation science skills. These new innovative elements, along with our strong leadership team, rigorous evaluation plan, and highly interdisciplinary mentors will ensure that we elevate the success of our Scholars and training program.